Modeling weekly and daily processes of a high-risk feedback cycle of alcohol, cannabis, and nonmedical use of prescription stimulants in college students: Impacts on use, academics, and sleep

PROJECT SUMMARY/ABSTRACT
Nonmedical use of prescription stimulants (NMPS) is most common among college students (American
College Health Association, 2023). NMPS has been associated with unwanted physical effects, sleep issues,
and lower GPA and is a marker for cannabis and alcohol use; up to 90% of adolescents and young adults who
engaged in past-year NMPS report using other drugs, particularly cannabis (Faraone et al., 2020; Kilmer et al.,
2021; McCabe et al., 2006b; NIDA, 2014). We test specific mechanisms of a high-risk feedback cycle of the
maintenance and escalation of NMPS, based on a novel framework grounded in the previous literature, with a
focus on alcohol use, cannabis use, and sleep difficulties (all of which are key public health concerns), and
academic stress. NMPS may be a compensatory behavior among those experiencing academic issues, which
may have resulted from cannabis/alcohol use and concomitant inconsistent class attendance (Arria et al.,
2013b). This feedback cycle operates continuously (not just during finals); therefore, it is critical to test the
mechanisms of the proposed feedback cycle across the entire academic quarter. Intensive longitudinal
research (e.g., weekly and daily surveys) is needed to best inform this important public health issue and
provide a critical, in-depth examination of how weekly fluctuations in academic and sleep issues may
contribute to NMPS and how daily fluctuations in alcohol use, cannabis use, and caffeine use may increase an
individual’s vulnerability. This R01 application will provide a critical, in-depth examination of the feedback cycle
focusing on NMPS, substance use, academics, and sleep. This project will recruit 300 college students (ages
18-25) who report (a) NMPS 5+ times in the past 12 months and (b) 4+ days of alcohol and/or cannabis use in
the past 30 days. Across two academic quarters, participants will complete 22 weekly online surveys as well as
two 21-day bursts of online morning surveys (corresponding with Fitbit sleep data). The aims are as follows.
Aim 1: Using weekly data, examine how the strength of the associations between the key components of the
feedback cycle vary as a function of time across the quarter. Aim 2: Using weekly data, test specific
mechanisms of the feedback cycle at the week level to identify which factors of the feedback cycle, when
elevated, confer heightened risk in a given week. Aim 3: Using daily data, test specific mechanisms of the
feedback cycle at the day level to identify which factors of the feedback cycle, when elevated, confer
heightened acute risk on a given day. Exploratory analyses will examine baseline moderators: class standing,
sex assigned at birth, gender, fraternity/sorority membership, symptoms of alcohol use disorder, symptoms of
cannabis use disorder, impulsivity, and sensation seeking. This application can inform our knowledge of the
behavioral mechanisms that contribute to substance use and will lead to refined interventions for students who
use multiple substances, enhancing our ability to target specific aspects of the feedback cycle.

Public health relevance
PROJECT NARRATIVE Nonmedical use of prescription stimulants (NMPS) constitutes a large public health concern given that NMPS is coupled with alcohol and cannabis use among college students (18-25 years old). This application tests a feedback cycle of the weekly- and daily-level processes associated with NMPS, alcohol, cannabis, caffeine, academic stress, and sleep difficulties. Findings will inform individual-level interventions that focus on the use of multiple substances among college students.